Community Engagement Core

PROJECT SUMMARY/ABSTRACT – Community Engagement Core
Morgan CARES (MC) is designed to be a vibrant learning community that supports community-campus
collaborations from inception through implementation and the dissemination of projects that address health
disparities, by providing supportive services and access to a strong infrastructure. Through the continuation of
this program we hope to 1) maintain and further expand to include the local Latino community in the Morgan
CARES learning community where members of the community and academia exchange their knowledge and
resources, and work toward achieving a dual mission of eliminating health disparities and producing new
generalizable knowledge; 2) further enhance the capacity for conducting and sustaining CBPR projects by
adding a clinical component for practitioner research as well as the provision of training, mentoring, and technical
assistance to students, junior investigators, and partner community members; and 3) facilitate the
communication and dissemination and translation of research findings into effective community-owned services
and interventions both locally and internationally. MC is housed in a renovated historical building in an
underserved neighborhood of East Baltimore. The facility serves as a hub for community and academic
partnerships to produce high-quality, community-led projects that contribute to the understanding of health
disparity issues and promote health equity. Furthermore, the facility serves as a physically accessible space for
creating a dynamic learning community where community and academic members network, share knowledge
and resources, and work toward eliminating health disparities while producing new generalizable knowledge.
MC also provides a wide range of free services including office space for meetings, a kitchenette, a space for
Community Based Participatory Research (CBPR) projects that involve youth, and access to computers and
printers for community use. Partnerships are formed and strengthened through research training, technical
support, workshops, classes, and community events and activities.